Defining epithelial polarity cues that direct cell fate

PROJECT SUMMARY
Numerous studies in mice and humans have established the proximal airway basal cells (BCs) as the major
multipotent stem cell population that maintains the integrity of pseudostratified epithelium through
differentiation to secretory, ciliated and goblet cells. Chronic pathologies affecting the respiratory epithelium
can bring about profound changes in BC biology, including BC exhaustion and dysfunction in chronic
obstructive pulmonary disease (COPD) as well as emergence of proliferative BC-like populations in cystic
fibrosis and cancer. Healthy luminal epithelial cells in the lung and trachea exhibit distinct apical-basal polarity,
and we have found that loss this polarity stimulates signals that promote aberrant BC expansion. In particular
our observations indicate that deletion of apical-localized transmembrane protein Crumbs3 leads to the
dysregulation of the transcriptional regulators Yap and Taz (Yap/Taz), which have emerged as essential
regulators of developmental and disease processes in the lungs and other organs. Our preliminary
observations lead us to hypothesize that aberrant nuclear Yap/Taz initiate and sustain intrinsic and extrinsic
signals in a microenvironment that promotes BC expansion. Analyses of polarity defective airways has
revealed an interesting Yap/Taz-Neuregulin-1(Nrg1)-ERBB positive feed-back signaling cascade that we
hypothesize promotes BC proliferation and self-renewal. We have also mapped notably changes in the
extracellular matrix microenvironment that we hypothesize stimulates distinct Integrin-relayed signals that
promote Yap/Taz activity, as well as identified a novel mesenchymal cell population that we hypothesize
mediates these microenvironment changes in response to aberrant epithelial polarity. We propose that
crosstalk between mesenchymal cells, extracellular matrix and the airway epithelium support aberrant BC
expansion in response to polarity damage. We propose to study and target the intracellular signals mediated
by Yap/Taz (AIM 1) and extracellular matrix alterations (AIM 2) that promote BC expansion, and further define
how mesenchymal crosstalk contributes to phenotypes associated with epithelial polarity damage (AIM 3). Our
studies will offer important molecular insight into aberrant BC expansion in airway disease, and if successful,
will reveal potential biomarkers and avenues for therapeutic intervention or targeting of these poorly
understood diseases, and potential new methods for expanding BC ex vivo for future regenerative therapies.

Public health relevance
PROJECT NARRATIVE An aberrant expansion stem-like cells is observed in a number of lung diseases, including chronic obstructive pulmonary disease (COPD), Cystic Fibrosis, and cancer. In this study we propose to use molecular and genetic approaches to define signals resulting from defects in airway epithelial architecture, which our observations suggest contribute to aberrant stem cell expansion and other disease phenotypes associated with lung diseases.